EpoxySEAKER and onSEAKER: CAR T-Cell Systems for Targeted Local Biosynthesis of Therapeutic Warheads

EPOXYSEAKER AND ONSEAKER: CAR T-CELL SYSTEMS FOR TARGETED LOCAL BIOSYNTHESIS OF
THERAPEUTIC WARHEADS
Our labs have developed novel SEAKER (Synthetic Enzyme-Armed KillER) CAR T-cells that express enzymes
that cleave masking groups from systemically administered non-toxic prodrugs. The localization of SEAKER
cells to tumors allows for specific conversion of the prodrug to anticancer agent at the site of interest. These
SEAKER cells overcome limitations of CAR T-cell therapy such as T-cell exhaustion, immunosuppression and
antigen variance by creating a cascade effect through proliferation of T-cells, constitutive secretion of enzymes
and catalytic generation of the active drugs. The enzymes continue to produce cytotoxic compounds at the tumor
site even after the T-cells functionally exhaust. We will engineer this system to produce novel
“epoxySEAKER” and “onSEAKER” cells that express bacterial biosynthetic enzymes and convert non-
toxic prodrug substrates into cytotoxic compounds through an enzyme-mediated therapeutic warhead
installation. Limiting the bulkiness of the prodrug by eliminating the need for masking moieties we expect greater
pharmacological properties of the prodrugs. Installing the warhead moiety onto the prodrug rather than cleaving
a masking group will eliminate the non-specific activation of cytotoxic agents and reduce the on-target, off-site
toxicity associated with the target compounds.
We plan to use our two novel SEAKER systems to target the tumor environment, elicit immunologic responses,
and subsequently secrete EpnF or TsnB9 which will enzymatically activate prodrug variants of FDA approved
drugs in situ. We will generate multiple prodrugs for the two SEAKER systems and evaluate their conversion to
the active compounds using recombinant enzymes in vitro. Compounds such as carfilzomib and panobinostat
are associated with on-target off-site toxicity when administered for the treatment of multiple myeloma. Tumor
targeting “epoxySEAKER” or “onSEAKER” cells will localize the secretion of synthetic enzyme to the
tumor site, allowing systemic administration of non-toxic prodrug, subsequent in situ compound
synthesis and reduced off-site toxicity demonstrated by the target compounds. The additive therapeutic
effect of the CAR-T cells and small-molecules will increase the effectiveness of treatment and may expand the
target scope of CAR-T cell therapy.

Public health relevance
We plan to engineer immunologic, cellular “micro-pharmacies” that specifically target cancer cells and secrete enzymes that activate non-toxic prodrugs at the site of the tumor. These systems will elicit an immune response to the tumor and control site-specific activation of anti-tumor molecules for many cancerous diseases.